Dartmouth-Boston University HIV-TB Research Training for the Infectious Disease Institute at Muhimbili University of Health and Allied Sciences

PROJECT SUMMARY/ABSTRACT
The previous three cycles of the Dartmouth-­Boston University-­Muhimbili (DBM) Fogarty HIV training program
have resulted in a multi-­faceted research and training collaboration between Dartmouth, BU and Muhimbili
University of Health and Allied Sciences (MUHAS). It has produced landmark studies on the epidemiology of
HIV, tuberculosis (TB) and HIV-­related TB (HIV-­TB), clinical features of adult and pediatric HIV-­TB, vaccine
trials to prevent HIV-­TB, and nutritional supplementation for women with HIV-­TB.
Our current 5-­year award culminated in MUHAS’ approval of a TB Research Institute (TRIM-­TB), which is an
HIV-­TB research collaboration between the DBM Fogarty program, MUHAS and the Tanzanian National
Programme on Tuberculosis and Leprosy (NTLP). Recognizing the benefits of TRIM-­TB, MUHAS leadership
endorsed the concept of a broader initiative, designated as the Infectious Disease Institute (IDI). The newly
approved IDI will support research and training in all infectious diseases of importance in Tanzania, with an
initial focus on HIV and TB. MUHAS, the NTLP and the National AIDS Control Program (NACP) have solicited
the DBM Fogarty Program to provide the training needed to achieve the IDI’s goals. To that end, we propose:
1) Train IDI research faculty to conduct HIV and HIV/TB epidemiologic research and clinical trials
2) Establish a mentoring program through IDI to ensure junior faculty are supported and successful in
performing research and obtaining independent research funding.
3) Expand the portfolio of funded collaborative HIV and HIV/TB research for MUHAS faculty/trainees.
4) Develop a program of research training for Tanzanian field scientists led by IDI faculty
To develop the present proposal, we conducted a comprehensive needs assessment including: 1) discussions
with key stakeholders/leadership at MUHAS, NTLP and NACP, 2) interviews with key MUHAS faculty, and 3) a
survey of DBM Fogarty alumni. In response, we focused our program on training in epidemiology, biostatistics
and clinical trials, developing strong Tanzanian mentors, expanding the research portfolio using NTLP and
NACP data, and supporting the IDI to develop its permanent research training program.
At the end of this proposed training program, 5 Tanzanian researchers will have graduated with PhD degrees
in epidemiology and/or biostatistics, 1 with a Masters degree in Epidemiology, and 4 with Masters of Public
Health degrees;; 18 will have completed short course training outside of Tanzania in epidemiology, biostatistics,
TB/HIV/STD research methods;; and over 150 will have attended interactive, hands-­on workshops in Dar es
Salaam on HIV-­TB clinical research, monitoring & evaluation, data analysis, and grant and manuscript writing.
This training program will provide the expertise to establish IDI as the premiere self-­sustaining research and
training institute for HIV and TB in East Africa.

Public health relevance
PROJECT NARRATIVE Our Dartmouth- Boston University- Muhimbili (DBM) Fogarty HIV training program will build on our prior Fogarty- supported capacity building activities and train research faculty to conduct HIV and HIV/TB epidemiologic research and clinical trials at the newly established Infectious Disease Institute (IDI) at Muhimbili University of Health and Allied Sciences (MUHAS). We will establish a collaborative mentoring program to ensure junior faculty are supported and successful in performing research and in obtaining independent funding as part of IDI’s research training program while also expanding MUHAS’ portfolio of funded HIV and HIV/TB research. This training program will provide the expertise to establish IDI as the premiere self- sustaining research and training institute for HIV and TB in East Africa.